TRACER Developmental Research Program

DEVELOPMENTAL RESEARCH PROGRAM: PROJECT SUMMARY
The Developmental Research Program (DRP) within this P20 Translational Research Center in Lung Cancer
Disparities (TRACER) application aims to select and support highly promising and innovative pilot research
projects to reduce health disparities in lung cancer. The TRACER MPI and DRP leadership (representing the 3
participating National Cancer Institute-designated cancer centers at Virginia Commonwealth University, Medical
University of South Carolina, and City of Hope) have set clear priorities for the selection of pilot research projects.
These priorities are (1) projects demonstrating exceptional translational science potential, (2) projects inclusive
of vertical and horizontal collaborations between the 3 participating institutions, and (3) projects with maximum
impact on the diverse communities serving—Virginia, South Carolina, and southern California. These pilot
research projects may include basic research explorations using human samples, diagnostic or treatment clinical
interventions in the form of clinical trials, or community-based prevention interventions. A major advantage of
this 3-institution P20 TRACER collaborative is that it provides immediate access to distinct urban and rural
regions with vastly different racial/ethnic compositions as well as cultural and environmental characteristics that
likely contribute to the disparities reported in lung cancer (e.g., large African American/Black populations in
Virginia and South Carolina and large Hispanic/LatinX and Asian populations in southern California, high rates
of smoking in Virginia and South Carolina; high levels of air pollution in southern California). The DRP will provide
direct and significant financial support for competitively selected pilot research projects and will provide these
pilot project PIs or investigative teams with access to the expertise and resources of the TRACER-supported
cores and an extraordinary list of other cutting-edge resources available within the 3 participating institutions.
The leaders of the DRP will select and fund a minimum of 3 pilot research projects annually, and the projects’
progress will be carefully monitored by multi-levels of internal and external scientific and community advisors.
The ultimate goal of the DRP is to establish a pipeline of research focused on the multi-dimensional causes of
lung cancer disparities within the diverse populations served by the partnering institutions and to develop the
preliminary data to support competitive research projects for a future, collaborative P50 SPORE application.

Public health relevance
DEVELOPMENTAL RESEARCH PROGRAM: PROJECT NARRATIVE The Developmental Research Program within this P20 Translational Research Center in Lung Cancer Disparities will select up to 3 pilot research projects annually that address different aspects of lung cancer health disparities. It is expected that the pilot research projects will fuel the preliminary data needed to compete as full research projects within a future P50 SPORE application.